Destabilization of axonal mRNAs by KHSRP complexes during axon regeneration

SUMMARY
This application asks how localized mRNA stability modifies axonal regeneration capacity, focusing on
contributions of the RNA binding protein [RBP] KHSRP. The nervous system makes extensive use of post-
transcriptional mechanisms to regulate cellular proteomes in response to extracellular stimuli and
physiologic environments during development, function, & in response to axonal injury. Since one mRNA
can be translated into protein many times over, how long a given mRNA is available for translation impacts
the amount of protein generated from that mRNA. Stability of mRNAs is indeed regulated, with
interactions with RBPs stabilizing & destabilizing different mRNAs, as well as interactions with microRNAs
targeting some targets for degradation. Translation of mRNAs clearly supports axon regeneration, but we
have little knowledge for how stability of axonal mRNAs is locally regulated. We have shown that the RBPs
HuD (also called ELAVL4) and KHSRP (also called FUBP2, MARTA1, & ZBP2) compete for binding to neuronal
mRNAs with AU-rich elements, where HuD interaction stabilizes and KHSRP interaction destabilizes target
mRNAs. At the molecular level, this interaction is impacted by an mRNA’s affinity for binding to HuD or
KHSRP. Our work over years 01-05 show that loss of KHSRP increases KHSRP target mRNA levels, causes
excessive axonal and dendritic growth, impairs memory consolidation in hippocampus & prefrontal cortex,
and increases presynaptic activity in prefrontal cortex and hippocampus. KHSRP is expressed into
adulthood, and we surprisingly find that axonal KHSRP levels rapidly increase in peripheral nerves after
injury. This increase in axonal KHSRP occurs through intra-axonal translation of its encoding mRNA. Our
preliminary data indicate that KHSRP knockout mice show accelerated nerve regeneration pointing to
axon-intrinsic functions for KHSRP in regeneration. Based on these observations, we hypothesize that
axonal KHSRP controls the rates of axon regeneration through regulation of localized mRNA stability. We
will test this hypothesis with the following specific aims: 1) Does KHSRP regulate PNS axon regeneration
through a neuron intrinsic mechanism? 2) Does increased axonal KHSRP limit axon regeneration by
destabilizing axonal mRNAs encoding regeneration-associated proteins? and 3) Does KHSRP’s protein
interactome influence its intra-axonal functions? Completion of the studies here will begin to fill this
knowledge gap by focusing on RNA-protein interactions initiated in axons that can affect mRNA survival.
This will provide the first subcellular analyses of RBP domain-specific RNA regulons and will bring the first
systematic assessment for contributions of RNA survival to peripheral nerve regeneration.

Public health relevance
PROJECT NARRATIVE There is a pressing clinical need to develop new strategies to both encourage and accelerate axon regeneration in the peripheral and central nervous systems; however, we need to understand the molecular mechanisms underlying what restricts rates of axon regeneration to the 1-2 mm/day seen for peripheral nerves. Translation of mRNAs in axons has been shown to promote axon regeneration; this proposal focuses how levels of those mRNAs are regulated to sustain localized protein synthesis and promote regeneration.